Microbial Chemical Sensing and Host Responses

Summary.
The tens of thousands of microbial metabolites produced by the trillions of bacterial cells that colonize our
intestines (our microbiota) are poorly understood, and current estimates suggest that we only know the biological
functions of 0.1% of all small molecules derived from the microbiota. Some of the metabolites in this so called
“dark matter” of the metabolome will undoubtedly have profound impacts on human physiology. Here, we will
establish how the human microbiome “communicates” with the host via dark-matter-derived molecular
modulation of host G protein-coupled receptors (GPCRs), including GPCR signaling effects mediated by
novel small molecules encoded by the microbiota (Aim 1a), GPCR signaling effects derived from endogenous
host chemicals (Aim 1b), and gut bacterial transformations of GPCR-targeted medical drugs that rewire chemical
signaling programs at the host-microbiota interface (Aim 2). A major focus will be the structural, functional, and
biosynthetic characterization of novel metabolites associated with “orphan” GPCR signaling where only limited
chemical and biological information is currently available. Our proposal takes advantage of the results from two
high-throughput screens and one targeted screen, which each focused on different aspects of how microbial
or host metabolism impacts host GPCR signaling at a detailed molecular level. In preliminary high-throughput
studies: 1) We have analyzed ~150 diverse human gut bacteria for secretion of metabolites that activate
conventional GPCRs (314 GPCRs) using a high-throughput GPCR screening system (Aim 1a). We have
characterized bacterial metabolites identified by this screen that activate three orphan GPCRs to date and have
thus established a pipeline for “GPCR deorphanization.” 2) We have screened human tissues for small molecules
that activate “orphan” GPCRs with no reported ligand information available (Aim 1b), providing a basis to
elucidate the structure and distribution of endogenous orphan GPCR signals. 3) We have evaluated the
processing of 271 FDA-approved drugs (including 62 GPCR-targeted drugs) by a panel of dozens of gut
microbiota-derived bacteria. This preliminary data includes 585,000 drug-by-microbiota measurements. Many
drug metabolism products and bacterial responses to drugs can be observed in the metabolomics data, guiding
the discovery of novel GPCR drug transformations and “specialized” metabolites from the gut microbiota whose
production is induced in response to GPCR drugs (Aim 2). The proposed studies will represent a heretofore
unprecedented structure-function-based exploration of the “dark matter” of the microbiota metabolome and how
it is “sensed” by the host. Such studies may illuminate novel GPCR- and microbiota-targeted therapeutic
strategies for a diversity of human diseases.

Public health relevance
Narrative. A large fraction of our current medical arsenal operates through G protein-coupled receptors (GPCRs). This interdisciplinary team proposal investigates three underlying molecular mechanisms of GPCR engagement at the host-microbiota interface – gut microbiota-derived GPCR ligands (Aim 1a), candidate endogenous GPCR ligands from human tissues (Aim 1b), and bacterial metabolism of and responses to GPCR drugs (Aim 2). The proposed studies will represent a heretofore unprecedented structure-function-based exploration of the “dark matter” of the metabolome at the host-bacteria interface and how it is “sensed” by the host, which could broadly illuminate new GPCR- and microbiome-targeted therapeutic strategies.